TESTOSTERONE REPLACEMENT--PROTEIN METABOLISM AND LEAN BODY MASS IN HYPOGONADISM

The role of androgen in body protein economy and to provide mechanistic correlates to the clinical course of hypogonadal patients undergoing testos rone treatment.